Animal model and resource development for preclinical lower urinary tract research

PROJECT SUMMARY
Neuromodulation is routinely used to treat overactive bladder, and more specifically urgency urinary
incontinence. Despite the therapeutic benefits of neuromodulation there remains room for improvement.
Preclinical animal models may be useful for elucidating the mechanisms of action of neuromodulation to
improve efficacy as well as to motivate new forms of neuromodulation. Recent work in our lab has suggested
that chronic electrical stimulation in animals, mimicking what is done in humans, may be critical for
understanding the mechanisms of neuromodulation. Although mouse models can be advantageous due to the
wide variety of genetic tools available for working with mice, executing chronic peripheral nerve stimulation
would be exceptionally challenging in mice. Rats are commonly used for studying the effects of acute
neuromodulation, but the animal models of overactive bladder and urgency incontinence are lacking. Instead,
healthy animals, or animals given chemicals to irritate their bladders (which may be more indicative of a pain
model) are used, with the hope that results translate. To test chronic neuromodulation in rats, as well as to test
other OAB therapies, there is a need for better rat models of OAB. As part of this Catalytic Tool and
Technology Development grant we propose the creation of dataset that measures urological function in 8
different rat strains at various points in time in their lifespan. Strains have been chosen due to their
characteristics which we think may impact their urological function (e.g., hypertension, obesity, diabetes, etc.).
We expect the data from the various rat strains to provide insights into how the urological function differs in
these strains, providing guidance to investigators who wish to use these strains in their urological research.
This dataset, along with other previously collected datasets, will be made public in a data portal designed
specifically to facilitate the sharing and reanalysis of preclinical urological data. Additionally data analysis tools
will be created and made public to facilitate consistent data analysis across studies.

Public health relevance
PROJECT NARRATIVE The process of using animal models to improve treatments works best when the model reflects some aspect of the dysfunction that is being treated. There is a need for animal models that reflect better the urinary dysfunction observed in people. In this project we test urological function in a variety of animal models and create a portal to share our data and the urological data of others, with the goal of accelerating the development of improved therapeutics for bladder dysfunction.